Miami Clinical and Translational Science Institute

Located in South Florida (SoFL), the goal of University of Miami’s Clinical and Translational Science Institute (CTSI) are to improve health outcomes in South Florida (SoFL) and beyond. The CTSI accomplishes these goals by catalyzing the development, demonstration, and dissemination of scientific and operational innovations that improve the efficiency, effectiveness, and quality of clinical and translational research. This is done through bidirectional engagement of patient advocates and community collaborators, to help identify gaps, challenges, and chokepoints in the translational research process. In response, the CTSI develops and test stakeholderdriven resources, tools, and interventions ultimately promoting the adoption and integration of those that are demonstrated to be successful, through dissemination and implementation efforts. This work is shaped by two primary factors: 1) SoFL embodies the evolving face of our nation, which enables CTSI Hub investigators to explore research questions difficult to conceptualize and evaluate elsewhere; and, 2) CTSI has a strong, successful and sustained record of authentic community and stakeholder engagement which facilitates multidisciplinary research that is grounded in the lived realities of the people that it is intended to serve. The CTSI’s focus, scope of activities and aims are grounded in an understanding of these factors and their complex interplay with one another. Together with community and patient stakeholders, the CTSI will: 1) support the development and dissemination of innovative resources and services to increase the quality, efficiency, and effectiveness of research across the entire translational research spectrum; 2) promote research collaborations aimed at facilitating and accelerating research to improve community health; 3) develop innovative training programs to support a team science-oriented CTS workforce, from translational scientists to clinical research professionals and key stakeholders; and 4) support CTS research responsive to these overarching goals. Through these efforts, the CTSI expects to achieve significant improvements in the quality, safety, efficiency, effectiveness, and informativeness of its Clinical and Translational Enterprise. The CTSI will then broadly disseminate its acquired knowledge regionally and nationally to maximize impact and opportunity, both now and in the future. By doing so, the CTSI accelerates bringing the benefits of translational science (more effective treatments, drugs, devices, behavioral interventions, and medical procedures) to all people.

Public health relevance
Project Narrative The goals of the University of Miami’s Clinical and Translational Science Institute are to improve the health of our community, address health disparities, and promote health equity. The CTSI will accomplish these goals by developing solutions to improve the efficiency of our research enterprise. In so doing, we will ensure that new discoveries and best practices equitably benefit the health of all patients and communities. PHS 398/2590 (Rev. 06/09) Page Continuation Format Page